Intercellular Communication in the Eye Lens

Project Summary
Lens, an avascular organ, relies heavily on a network of transporting systems to deliver nutrients and other
essential components to bulky lens fibers and excrete wastes. Differentiated nuclear fiber cells never turn over,
and oxidative stress is a major cause of age-related cataracts. Fluid flow associated with lens microcirculation
is thought to help deliver nutrients, antioxidants, and small molecules to inner lens fibers. Connexin (Cx)-
forming gap junction channels (GJs) play an essential role in the metabolic homeostasis of the lens. Besides
GJs, connexins form hemichannels (HCs), permitting the transport of molecules between the cell and its
extracellular environment. Our preliminary studies indicate that lens epithelial HCs are activated by FSS and
release GSH and ATP; these released factors protect lens fiber cells against oxidative stress and promote lens
fiber differentiation, respectively. As such, we hypothesize that (1) The epithelial HCs formed by Cx43 and/or
Cx50 activated by FSS regulate GSH de novo synthesis, release, and redox hemostasis; (2) GSH released by
epithelial HCs is taken up by HCs in cortical fiber cells and transferred to nuclear fiber cells to maintain lens
fiber cell redox homeostasis and viability; (3) Epithelial HCs activated by FSS generate secretomes and
released ATP, and its binding to purinergic P2X receptors (P2XRs) (i.e., P2XR3 or/and P2XR7) regulate Ca2+
signaling and fiber cell differentiation. The goal is to elucidate the roles of lens epithelial HCs activated under a
physiological level of mechanical stimulation in hemostasis, differentiation, and protection against oxidative
insults in lens fiber cells. In this proposal, first, we will determine if Cx HCs activated by FSS serve as a major
pathway in regulating GSH synthesis, export, and redox homeostasis in lens epithelial cells. Second, we will
test if GSH released by lens epithelial HCs is taken up by mechano-activated HCs in cortical lens fibers and
transferred to nuclear fibers via GJs functions in reducing ROS and protecting fiber cells against oxidative
stress. Third, we will determine if ATP released by lens epithelial HCs and activation of purinergic receptor
signaling regulates fiber cell differentiation and globally investigate secretomes by FSS-activated epithelial
HCs. One of the major innovative aspects is that this proposal aims to uncover novel, integrated roles of Cx
HCs in lens epithelial and fiber cells and GJs in antioxidant transport, fiber cell protection, and the role of ATP
released by epithelial HCs and activated P2XRs in lens fiber differentiation. We will use chick primary lens
cultures, chick lens in situ, ex vivo mouse lens explants of wild-type and knockout mice, HC-specific inhibiting
antibodies, dominant mutants, and mechanical loading models. It is our expectation that elucidation of the
mechanistic roles of Cx channels in lens cells will provide a better understanding of the key homeostatic
process of the lens. The outcomes of our research will be significant because the discoveries should make
novel and beneficial contributions to new therapeutic strategies and identify drug targets for the treatment of
lens disorders, such as age-related cataracts.

Public health relevance
Public Health Relevance Cataracts are one of the most common eye diseases and also a leading cause of blindness worldwide. Connexins play important roles in lens cell homeostasis, and mutations in connexin genes lead to human congenital cataracts. The proposed research activity will help in understanding how connexin channels mediate the transport of antioxidants and other important biological molecules and should make novel contributions to new ideas and strategies for drug discovery and development in the treatment of cataracts.